Chicken embryonic stem cells

Abstract
Chickens and their embryos provide a valuable research model for the study of developmental biology and
human diseases. However, their application has been greatly limited due to the lack of tools to genetically
modify chickens and other avian species. Recently, we have developed methods for the derivation of germline
competent embryonic stem cells (ESCs) from chickens. The availability of germline competent chicken ESCs
opens up a new avenue for producing genetically engineered chickens. In this project, we propose to establish
an ESC-based platform for the efficient generation of chicken germline chimeras (Aim 1). We will also optimize
methods for the generation of primordial germ cells (PGCs) from chicken ESCs. These chicken ESC-derived
PGCs will be used to produce genetically modified chickens (Aim 2). In Aim 3, by taking the advantage of the
chicken ESC culture condition we have established, we will develop methods for the generation of induced
pluripotent stem cells (iPSCs) from chicken embryonic fibroblasts. Successful completion of these three aims
will provide the avian research community with a powerful genetic toolkit for the production of transgenic and
gene-targeted avian species and for the conservation of endangered avian species.

Public health relevance
Narrative Chickens and other avian species provide a good model for the study of human diseases; however, their use has been greatly limited due to the lack of tools to genetically modify them. We have for the first time established authentic embryonic stem cells from chickens and other avian species. We will use these embryonic stem cells to develop a genetic toolkit for the generation of transgenic avian species for the study of human diseases and for conservation of endangered avian species.